Investigate heterogeneous neutrophils in NSCLC

After identifying SiglecF+ neutrophils as a unique neutrophil subgroup in a genetically engineered mouse model of lung adenocarcinoma, we successfully generated a mouse model specifically deleting SiglecF protein in neutrophils (Ly6G-Cre; SiglecF-flox). Our preliminary data showed an increased tumor burden after knocking out SiglecF protein in neutrophils. We are studying the downstream changes in these groups of neutrophils. Meanwhile, we performed advanced single-cell RNA sequencing with single-cell ATAC sequencing. We discovered the development trajectory of tumor-associated neutrophils in the tumor microenvironment (TME) and potential transcription factors driving this process. We also established a platform to knockout or overexpressed target proteins in neutrophils via CRISPR-Cas9 technology. We are currently validating transcription factors that may regulate SiglecF expression and neutrophil development in TME.